Unraveling the Role of Microenvironmental Chemokines in Beta-Catenin/TCF Signaling and Gene Occupancy during Colorectal Cancer Metastasis to the Liver and Lung

Dr. Jonathan Rennhack is a senior postdoctoral fellow in the lab of Dr. William Hahn at Dana-
Farber Cancer and the Broad Institutes pursuing an independent position with the long-term goal
to lead a basic and translational research laboratory geared towards understanding epigenetic
and genetic drivers of tumor metastasis. Dr. Rennhack proposes to leverage molecular
techniques, patient derived organoids, and mouse models of metastatic dissemination to define
critical molecular pathways in metastatic survival of colorectal cancer. This work will also define
the microenvironmental signals that cause necessary molecular changes which promote
metastatic survival. Due to the significant contribution that metastasis has in the mortality of CRC
patients, this is in line with the NCI’s goal to help cancer patients live longer.
Dr. Rennhack analyzed genomic, transcriptomic, and enhancer profiles of primary and metastatic
colorectal cancer specimens and found liver-derived CCL2 directly promotes the survival of
metastatic liver lesions by increasing the expression of the β-catenin partner protein, TCF7. He
has shown this network to be critical for continued growth and survival of the metastatic lesion in
the liver. However, it remains unknown if the CCL2/TCF7 signaling node is necessary for other
sites of metastatic dissemination such as the lung.
Preliminary data indicates that other TCF family members are expressed in other sites of
metastatic dissemination and could be critical for mediating survival of metastatic lesions in those
organs. Based upon this preliminary data it is hypothesized that the metastatic microenvironment
influences β-Catenin/TCF complex composition and DNA binding to promote differential gene
profiles critical for survival in the lung and liver. This hypothesis will be tested using two
interrelated but independent aims. In the first aim the composition and occupancy of the β-Catenin
complex during metastatic dissemination to the lung will be defined and functionalized. In the
second aim microenvironmental regulators of the β-catenin complex, and subsequently survival
within the metastatic microenvironment will be defined and functionally tested.
In addition to the scientific directives outlined above, Dr. Rennhack will receive additional training
in laboratory management, mentorship, grantsmanship, bioinformatics, and translational science
throughout the K22 award. Together the experiments proposed, and the additional training
provided in this award will ensure Dr. Rennhack’s success as he transitions to an independent
research position and will ensure he obtains additional research funds within the first two years
of this award.

Public health relevance
PROJECT NARRATIVE Metastatic disease is the leading cause of death of colorectal cancer patients. However, the molecular mechanisms underlying cell dissemination and survival within the liver and lungs remains poorly understood. In this study, we aim to elucidate the protein complex compositions and microenvironmental regulators in colorectal cancer metastasis which drive metastatic outgrowth and identify new targets for therapeutic intervention in advanced colorectal cancer.